Exploration of Contemporary Modifiable Exposures and Cancer in Beauty Salons

PROJECT SUMMARY/ABSTRACT
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA-
24-030: Administrative Supplements for Contemporary Modifiable Exposures and Cancer Across the Life Course
and Cancer Control Continuum. Black women are 40% more likely to die from breast cancer and twice as likely
to die from cervical cancer than their White counterparts. A myriad of plausible causes for this disparity have
been proposed including genetic, biological, social, and environmental factors (including contemporary
modifiable exposures). The possible cumulative impacts of these factors on cancer risk among environmental
justice communities has been understudied. The goal of this administrative supplement to the UPMC Hillman
Cancer Center Support Grant (P30CA047904-34) is to generate preliminary data to advance our understanding
of the potential cumulative impact of biological and social determinants of health and contemporary modifiable
exposures to endocrine disrupting chemicals in beauty salons (e.g., chemical hair relaxers) on risk of cancer
among Black women. Study findings will inform potential cancer risk reduction interventions for our Community
Outreach and Engagement (COE) office and generate catchment relevant research questions among our
multidisciplinary investigative team with expertise in cancer health disparities, epidemiology, environmental
health, and basic science.

Public health relevance
PROJECT NARRATIVE Black women in the United States have worse outcomes and higher mortality from breast and uterine cancer than any other racial/ethnic group. The UPMC Hillman Cancer Center has assembled a multidisciplinary team with expertise in cancer health disparities, epidemiology, environmental health, and basic science to conduct a preliminary evaluation of whether environmental and social determinants of health modify risk of chemical beauty products in the development of breast and uterine cancer among Black women.